Basic Research Forum for Emerging Kidney Scientists

Maintaining the kidney research workforce is a major challenge. Therefore, there is an urgent need for programs supporting kidney research trainees and early career investigators to provide support for the next generation of investigators. Now in its third year, the Basic Research Forum for Emerging Kidney Scientists is co-sponsored by the American Society of Nephrology (ASN) and the American Physiological Society (APS), with both societies making substantive contributions to meeting success. The meeting’s primary objectives are: 1) to foster the scientific development of trainees and early career investigators by providing opportunities for young investigators to formally present their research and informally discuss their science with peers and established investigators; 2) to enhance innovation in kidney research by bringing together scientists across kidney research disciplines in an interactive and informal setting; 3) to provide opportunities for trainees and early career investigators to meet one another, establishing and fortifying trainee “cohorts” who will progress in their careers together; 4) to provide opportunities for trainees and early career investigators to meet established investigators who may become future collaborators, mentors or sponsors; and 5) to teach trainees and early career investigators important non-experimental skills needed for career success in biomedical research by providing career development activities. The Basic Research Forum is unique amongst kidney research-related meetings in that it is solely focused on trainees and early career investigators (“young investigators”). The meeting will be held on October 21, 2020 at the Colorado Convention Center, a highly accessible site with accommodations for participants with disabilities. Short oral presentations will be selected from abstracts submitted by young investigators, with time for questions from peers and established investigators. Women and individuals from groups under-represented in biomedical science are vulnerable to the “leaky pipeline,” and particular attention will be paid to their inclusion. Ample time is provided for networking and interactions amongst young investigators and with established investigators, including lunch groups encompassing a variety of career stages. Career development activities are designed to meet the needs of trainees at various career stages to get advice and learn skills required for success. Established investigators with varying research interests will participate in all aspects of the meeting. The Basic Research Forum is a small meeting taking place within a much larger meeting (ASN Kidney Week, the largest international kidney meeting each year) that draws scientists from around the world engaging in a very broad spectrum of kidney research. This allows young investigators to interact with scientists from diverse sub-fields of kidney research, fostering cross-talk and innovation and strengthening trainee cohorts. The expected outcomes are that the Basic Research Forum for will strengthen all areas of kidney research by promoting interactions amongst the next generation of researchers, improving innovation and strengthening the kidney research workforce now and in the future.

Public health relevance
NARRATIVE Increasing numbers of people are living with kidney disease in the U.S. The goal of this conference is to support the scientific and career development of trainees and young investigators engaged in different types of basic kidney research by giving them an opportunity to present their research, network with each other and established investigators, and participate in career development activities. Providing support for the next generation of researchers will bring transformative innovation to understanding, diagnosing, and treating kidney disease.